Connecticut Department of Agriculture - Maintenance of the Animal Feed Regulatory Program Standards - 2025

CONNECTICUT DEPARTMENT OF AGRICULTURE
450 Columbus Blvd, Suite 702 | Hartford, Connecticut 06103 | 860.713.2500
www.CTGrown.gov
Department of Regulatory Services
Affirmative Action/Equal Employment Opportunity Employer
Project Abstract:
Connecticut Department of Agriculture Conformance and Maintenance with the
Animal Feed Regulatory Program Standards (AFRPS)
Since the beginning of the Animal Feed Regulatory Program Standards (AFRPS), Connecticut
Department of Agriculture (DoAg) has been devoted to developing, maintaining and improving
the Connecticut Animal Feed Program and helping achieve a nationally integrated food safety
system. A 5- year AFRPS Cooperative Agreement that concluded on June 30, 2025 helped DoAg
drastically improve the Connecticut Animal Feed Program by establishing standard operating
procedures for each of the standards, establishing a risk-based inspection program, establishing
an online registration, inspection and risk assessment, standardize animal feed sampling, and
outreach.
Through the original AFRPS Maintenance Cooperative Agreement, DoAg maintained, updated and
improved the standard operating procedures and the Feed Program as necessary for the last 5
years. We are current applying for an additional 3-year term to maintain and improve the
Connecticut Animal Feed Program. The specific goal of this continued funding with the AFRPS
Maintenance Cooperative Agreement will help DoAg to continue our efforts to improve the
Connecticut Animal Feed Program and advance efforts at achieving a nationally integrated food
safety system. In conjunction with a feed sampling contract, we will be conducting inspections on
applicable feed manufacturing firms in Connecticut, collaborate with other states and federal
agencies on feed related issues, conduct audits, complete animal feed trainings and continued
education, collecting feed samples and conducting complaint investigations along with other
animal feed related duties.
1

Public health relevance
CONNECTICUT DEPARTMENT OF AGRICULTURE 450 Columbus Blvd, Suite 702 | Hartford, Connecticut 06103 | 860.713.2500 www.CTGrown.gov Department of Regulatory Services Affirmative Action/Equal Employment Opportunity Employer Project Narrative: Connecticut Department of Agriculture Conformance and Maintenance with the Animal Feed Regulatory Program Standards (AFRPS) The Connecticut Department of Agriculture (DoAg) just concluded 5 years of successful partnership with FDA for the maintenance of the Animal Feed Regulatory Program Standards. DoAg is applying for an additional 3-year term to maintain and improve the Connecticut animal feed program. Thank you for reviewing this application for work to achieve the FDA goals of a nationally integrated food safety system. DoAg is applying for the AFRPS Maintenance Track where we will continue to maintain full implementation with the current AFRPS to enhance the nationally integrated food safety system. DoAg will participate in regularly scheduled visits with FDA and collaborative regulatory activities to discuss DoAg AFRPS program and if any improvements or modifications are necessary. DoAg will maintain implementation with the current AFRPS however if implementation is not maintained then DoAg will utilize the developed strategic improvement plan to expedite and correct the issue at hand. DoAg will participate in scheduled assessments by the FDA Audit Staff to verify implementation status and DoAg’s next scheduled audit is planned for October 2025. DoAg will continue to attend and participate in the AFRPS Face to Face meetings. In the past, DoAg has participated by presenting at the Face to Face and participated in panel discussions. The Connecticut Agricultural Experiment Station(CAES) is DoAg’s state regulatory lab for any routine animal feed samples and CAES participates in the Laboratory Flexible Funding Model. DoAg maintains and Animal Feed Contract with CAES to plan for what routine samples DoAg will be collecting that year. CAES and DoAg have an annual meeting to discuss that contract and then several conversations throughout the year to discuss the progress of sampling. DoAg participates in biweekly RRT calls and completes any forms if necessary. DoAg has also attended RRT annual meetings. DoAg agrees to communicate with FDA and any other applicable state/federal agency if a violative LFFM samples is outside of DoAg’s program jurisdiction. DoAg will collect animal feed samples at the manufacturer, retail locations and any other locations in accordance with the collection instructions for each hazard -commodity pair on the approved LFFM sample plan. DoAg will conduct investigations and use applicable enforcement action on violative samples. 1